Unintrusive Pediatric Logging Orthotic Adherence Device: UPLOAD

PROJECT SUMMARY/ABSTRACT
The application’s broad objective is to create a product that is able to improve remote compliance monitoring in
pediatric orthotics applications by creating a device that combines all of the ideal compliance monitoring features
into a single device called the Unintrusive Pediatric Logging Orthosis Analytic Device (UPLOAD). Our initial
focus is on pediatric orthotic populations due to the short treatment window and demonstrated clinical efficacy
in these populations. Longer term, we can leverage the technical backbone and data ecosystem being advanced
with this project for other monitoring needs (e.g., falls in both prosthetics and orthotics, more advanced AFO or
prosthesis compliance requiring more than two years of battery life, cranial remolding orthosis pressure
monitoring, etc.).
The key focus of the proposed project is to determine the feasibility of creating a commercially available device
that has all of the following features: unintrusive size, battery life that lasts at least as long as the time between
brace replacements, low cost, and most importantly real time remote access to the sensor data in a way that
does not require any additional hardware or effort from the parent/patient after initial setup.
The specific aims of the project are to develop specifications, perform technical development of the UPLOAD
system, and then perform benchtop verification testing to confirm the feasibility of the meeting the identified
specifications.
The research design and methods for achieving the stated objectives include requirements gathering (including
conducting an expert panel) and specification document development, prototype design (including component
identification, prototype hardware development, power budgeting and component selection, and alternative
energy harvesting), technical development (including custom hardware design, firmware development, mobile
application development with cloud infrastructure, and clinician dashboard and report generation), sensor
integration method development, verification testing (including functional testing, battery life characterization and
performance testing), design refinement, and management and reporting.
This project is relevant to the mission of the National Institutes of Health because it applies knowledge to enhance
health and reduce disabilities of patients with adolescent idiopathic scoliosis (AIS) and deformational head
shapes.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it aims to enhance compliance monitoring in pediatric orthotics, which is an intervention that is proven to improve clinical outcomes in patients with conditions such as adolescent idiopathic scoliosis (AIS). This research will contribute to the application of knowledge to reduce disabilities and enhance the health of patients with AIS and deformational head shapes by creating a device that will possess a full suite of features to improve compliance monitoring in patients with these conditions. This improvement will occur by providing an effortless method for clinicians to remotely monitor compliance in real time.